Regenerative Rehabilitation of Complex Musculoskeletal Injuries

SUMMARY
Complex musculoskeletal trauma is common both in combat and high energy civilian accidents and often leads
to prolonged disability or skeletal nonunion. Regenerative rehabilitation is an emerging field with the potential to
improve functional outcomes for lower limb musculoskeletal trauma patients. Our overall objectives are to (i)
investigate rehabilitative loading as a regenerative rehabilitation treatment strategy for severe complex
musculoskeletal trauma and (ii) understand the relationship between rehabilitative loading, local regenerative
niche mechanics, and the biological response. We will meet these objectives through the following specific aims.
Specific Aim 1: Determine the effects of rehabilitative loading, injury severity and sex on regenerative
niche mechanical signals and functional regeneration. In a rat model of a femoral bone defect, we will employ
a factorial experimental design to determine effective rehabilitative loading protocols in critically sized injuries,
and determine the effects of rehabilitation on local and systemic biological responses and functional regeneration
as a function of sex and injury size. Specific Aim 2: Integrate sensor-enabled real-time feedback into
rehabilitation protocols and test the ability to accelerate bone and muscle functional recovery following
severe extremity injury. This aim will use wireless implantable strain sensors to provide noninvasive monitoring
of mechanics in the regenerative niche throughout the progression of healing under rehabilitative loading. Sensor
mechanical data will be used to identify strain ranges that serve as early indicators of healing status and are
used as a criterion for dynamically adjusting the rehabilitation regimen on a subject-specific basis to accelerate
functional regeneration of musculoskeletal tissue. Specific Aim 3: Build predictive multivariate models based
on co-dependent relationships among local regenerative niche mechanical parameters, systemic
biomarkers, and functional regeneration. Finite element modeling will be used to generate simulated strain
maps showing local variations in regenerative niche mechanical signals using implantable sensor measurements
as time-varying boundary conditions. Linear multivariate analyses will be used to map spatial and temporal
relationships between the biological responses and local regenerative niche mechanics under rehabilitative
loading regimens. Integrating early mechanical data and systemic biomarker data from the previous aims,
nonlinear symbolic regression will be used to develop predictive models of bone and muscle functional outcomes
for subjects of both sexes. These models will be tested in a prospective study using an additional cohort of both
sexes to validate whether models developed in one sex can be predictive of healing outcomes in both the same
and the opposite sexes.

Public health relevance
PROJECT NARRATIVE Complex musculoskeletal extremity trauma is associated with high complication rates and poor rates of functional recovery. The proposed work is significant because effective integration of local regenerative treatment strategies and rehabilitation protocols has the potential to reduce surgical revision procedures and may be essential to achieve full restoration of limb function following severe musculoskeletal trauma.